Regulation of Cerebral Blood Flow

[unreadable] DESCRIPTION (provided by applicant): Hypoxia-ischemic injury in the neonate represents a major medical problem in the U.S.A. and results in neurological sequelae and death. Current treatment regimens are not optimal and there is a need for new therapeutic approaches. A novel experimental approach first described by us in the brain and cerebral circulation involves the initiation of immediate and delayed preconditioning against anoxic stress by the selective activation of mitochondrial ATP-sensitive potassium (mitoKATP) channels. No previous studies have systematically examined the dynamics and mechanisms of pharmacological preconditioning in brain tissue or the vasculature of neonatal or adult animals. Furthermore, use of several selective mitoKATP channel openers will clarify the mechanisms of preconditioning. We have created two specific aims to test our hypotheses and speculations in piglets: Specific Aim 1. Examination of the effects of mitoKATP channel activation without ROS production in immediate and delayed protection of brain and vasculature after IR. We will test the hypothesis that immediate and delayed preconditioning have distinct "windows" and that only mitoKATP channel activation and not linked ROS production is necessary for the initiation and expression of immediate and delayed neuro- and vascular-protection. First, we will define temporal windows for the immediate and delayed phases of protection against anoxic stress. Second, we will assess whether preconditioning via mitoKATP channel activation occurs in cerebral blood vessels as well as in neurons. Third, we will document that preconditioning occurs in the absence of ROS generation. Specific Aim 2. Determination of the mechanisms of mitoKATP channel activation in immediate and delayed protection of brain and vasculature after IR. We will test the hypothesis that initiating events are similar, but subsequent mechanisms underlying immediate and delayed preconditioning are different. First, we will assess the role of protein kinase C (PKC) activation as a key component of preconditioning. Second, we will investigate the mechanisms by which mitoKATP channel activation limits calcium influx and mitochondrial swelling during immediate preconditioning. Third, we will explore the mechanisms by which mitoKATP channel activation leads to reduced ROS production during delayed preconditioning. We expect that our studies will lead to the development of therapies which will lessen the severity of neurological injury to ischemia in the neonate. [unreadable] [unreadable] [unreadable]